Cellular and circuit function of Ndnf-expressing interneurons in a mouse model of a neurodevelopmental disorder

PROJECT SUMMARY/ABSTRACT
Each year, 1 in 6 children are diagnosed with a neurodevelopmental disorder such as autism spectrum disorder,
intellectual disability, or epilepsy. Such disorders severely impact the emotional, social, physical, and economic
wellbeing of patients and their caregivers, and a poor understanding of the underlying pathophysiology of these
disorders has slowed the discovery of effective therapies. There is evidence, however, that neurodevelopmental
disorders as a class are associated with selective dysfunction of GABAergic inhibitory interneurons in the
cerebral cortex.
Dravet Syndrome, caused by pathogenic variants in the SCN1A gene encoding the Nav1.1 voltage-gated sodium
channel a subunit, is a canonical example of a neurodevelopmental disorder caused by interneuron dysfunction,
as interneurons in the neocortex preferentially rely on Nav1.1 for action potential generation and propagation.
Importantly, cerebral cortical interneurons are a functionally heterogenous population; therefore, understanding
the contribution of different classes of interneurons to microcircuit function in normal brain, and dysfunction in
the setting of pathology, is essential for further elucidating the mechanisms of neurodevelopmental disorders.
In this proposal, I will determine the function or dysfunction of the least studied major population of neocortical
interneurons, those expressing Neuron-Derived Neurotrophic Factor (Ndnf), within cerebral cortical microcircuits
in Dravet Syndrome. These cells are enriched in layer 1 of neocortex, where they are thought to play a role in
sensory processing and regulating inhibitory tone in the cortex. Using a clinically-relevant and well-characterized
mouse model of Dravet Syndrome, I will first establish the electrophysiologic, synaptic, and morphologic
properties of Ndnf-expressing interneurons in Scn1a+/- mice relative to wild-type mice in vitro (Aim 1). I will then
determine the behavior of these cells within cortical microcircuits in Scn1a+/- mice relative to wild-type in vivo
using multiphoton imaging and optogenetic approaches (Aim 2). This proposal will not only provide novel data
on an understudied interneuron subtype, both in health and disease, but also provide training in a suite of
advanced electrophysiologic and optical techniques that will serve to train the applicant towards a future career
as a physician-scientist studying circuit dysfunction in neurological disorders and development of new therapies
and cures.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental disorders – including epilepsy, intellectual disability, autism spectrum disorder, and schizophrenia – have a significant and chronic impact on the quality of life of up to 1 in 6 children in the United States. Dravet Syndrome is a neurodevelopmental disorder characterized by treatment-resistant epilepsy, intellectual disability, and autism spectrum disorder, with a known causative genetic mutation and a well- validated clinically-relevant animal model, which allows for studies of disease mechanism and development of new treatments. This proposal uses electrical recording, neuroanatomy, and state of the art imaging techniques in an experimental model system to further our understanding of the pathophysiology of Dravet Syndrome with the goal of generating targets for novel therapies for neurodevelopmental disorders.